EPSTEIN-BARR VIRUS IN MOUTHWASH

In order to better characterize oral EBV shedding and viral strain associations in subjects with and without human immunodeficiency virus infection, mouthwashes collected from subjects overtime were studied by polymerase chain amplification of strain variable regions of the EBV genome.